Diet Interventions: Remitted and Evaluated as Complementary Treatments for Pain (DIRECTPain)

Knee osteoarthritis (OA) is the most prevalent form of arthritis and a significant cause of lost productivity in the U.S. As the population ages and obesity rates increase, the rates of knee OA climb as well, impacting quality
of life (QOL) for millions. Current national efforts to reduce analgesic utilization highlight the critical need for safe and effective alternatives for pain relief. Low-carbohydrate diets (LCDs) reduce inflammation and pain
independent of weight loss, indicating that diet interventions offer a non-pharmacological complementary treatment. However, differences between individuals exist in metabolism that are rarely addressed in diet
interventions. Thus, it is important to assess the potential of different diets in a broad population of chronic pain sufferers to determine the potential of diets to reduce knee OA pain. Here, we will recruit adults (n=200) with
knee OA to complete our two-phase protocol. Phase 1 will involve a 1-week diet run-up that will allow for quantification of pain measures, psychosocial variables (socioeconomic status, nutritional knowledge, proximity
to grocery stores, food insecurity), and diet quality to provide a baseline for comparison. Phase 2 will be a 6-week diet intervention (LCD or USDA diet) in which both groups will be provided with all meals at the direction
of study personnel and input from participants. Evoked pain tasks, measures of pain severity, catastrophizing, and interference will be assessed every 3 weeks in addition to QOL measures, mood, and depression.
Physiological variables will be assessed through blood draws (inflammatory profile) and dual-energy X-ray absorptiometry scans (DXA; body composition, visceral fat) at the end of Phases 1 and 2. This will be the first
study to examine the efficacy of these diets to reduce knee OA pain and interactions with biopsychosocial variables. Changes in all pain measures following Phase 2 will be assessed with respect to published
measures of clinically-meaningful differences in pain, as well as for statistical significance. The central hypothesis is that the LCD will improve pain and QOL in participants with knee OA more than the USDA diet,
but that both will be beneficial.

Public health relevance
Diets may be a viable, accessible and efficacious adjunct treatments to reduce the pain associated with knee OA in older adults. The overall aim of this study is to examine the efficacy of a 6-week intervention with either the LCD or the USDA diet to reduce evoked pain and increase quality of life in those with knee OA. We believe that there will be differential effects of the diets on multiple measures and that diet interventions will be demonstrated as a safe and healthy means to reduce pain.